Changes in Bone Quality, Sarcopenia and Fat Distribution in HIV/HCV Patients after HCV Therapy

PROJECT SUMMARY/ABSTRACT
Coinfection with hepatitis C virus (HCV) is common among HIV infected patients. HIV exacerbates HCV-
related metabolic complications, and coinfected patients have a higher risk of sarcopenia, visceral adiposity,
hepatic steatosis, and bone fracture than those with HCV alone, HIV alone, or uninfected persons. Importantly,
each of these metabolic complications is associated with morbidity and mortality in HIV+/HCV+ patients.
Despite the high prevalence of these abnormalities among HIV+/HCV+ patients and their adverse impact on
survival, the underpinnings for the sarcopenia, fat alterations, and skeletal fragility have not been established.
Understanding the associations among muscle mass/strength, fat mass/distribution, and bone strength in
HIV+/HCV+ patients, how they differ from those of HCV+ and uninfected persons, and their relations with levels
of inflammatory cytokines (interleukin-6 and -18; tumor necrosis factor-α) and insulin-like growth factor-1 (IGF-1)
will shed light on the relations between HIV/HCV infections and musculoskeletal health, fat distribution, and the
role of inflammation. Further, it is unknown if cure of HCV with direct-acting antiviral (DAA) therapy ameliorates
these abnormalities, and if the degree of improvement is similar for HIV+/HCV+ and HCV+ patients.
To address these knowledge gaps, we will assemble three cohorts of patients: 1) HCV treatment-naïve
HIV+/HCV+ coinfected patients initiating DAA therapy, 2) treatment-naïve HCV+ monoinfected patients
initiating DAA therapy, and 3) uninfected persons. We will prospectively follow both HCV infected cohorts from
the start of DAA therapy through 12 months after cure of HCV (18-month period) and the uninfected cohort
over 18 months. We hypothesize that HIV and HCV-associated inflammation (mediated by interleukin-6,
interleukin-18, and tumor necrosis factor-α) and IGF-1 are key determinants of the abnormalities in body
composition and bone fragility in HIV+/HCV+ patients. We further hypothesize that cure of HCV will result in
significant decreases in these cytokines and an increase in IGF-1 that will lead to improvements in muscle
mass/strength, visceral adiposity, hepatic steatosis, and bone strength, but less so for HIV+/HCV+ patients.
Aim 1 will compare muscle mass (by dual-energy X-ray absorptiometry), muscle strength; MRI measures of
subcutaneous, visceral, and intra-hepatic fat; and bone microarchitecture/strength by high resolution-peripheral
quantitative CT across the cohorts at enrollment and evaluate the cytokines and IGF-1 as determinants of
these outcomes. Aim 2 will examine the effect of cure of HCV with DAAs on the cytokine and IGF-1 levels in
HIV+/HCV+ and HCV+ patients and their associations with subsequent changes in muscle, fat, and bone
compared to changes in uninfected persons over the same time. The completion of these aims will address
critical knowledge gaps on the determinants (particularly inflammatory cytokines and IGF-1) of sarcopenia, fat
alterations, and skeletal fragility in HIV+/HCV+ patients, yield fundamental information on the reversibility of the
abnormalities after cure of HCV, and identify determinants of improvement in muscle, fat, and bone strength.

Public health relevance
PROJECT NARRATIVE HIV/hepatitis C virus (HCV) coinfection is associated with sarcopenia, visceral adiposity, hepatic steatosis, and bone fracture, all of which contribute to morbidity and mortality in this group. The proposed study will provide important insights into the determinants of each of these abnormalities in HIV+/HCV+ patients and examine whether they improve after cure of chronic HCV. The results are likely to impact clinical practice by informing recommendations to improve muscle mass/strength, hepatic steatosis, and bone health in coinfected patients and could provide additional indications for direct-acting antiviral-based HCV therapy, which will lower the incidence of metabolic complications and prolong survival in the HIV+/HCV+ population.